ACCESS TO THE 8TH EDITION OF THE CANCER STAGING MANUAL AND THE VERSION 9 CANCER STAGING SYSTEM

Update CLIN 4: ACCESS TO THE 8TH EDITION OF THE CANCER STAGING MANUAL AND THE VERSION 9 CANCER STAGING SYSTEM